Single Cell Characterization and Procurement Core

SCCPC Abstract
As a direct result of our ability to analyze hematopoietic cells at the single cell level, our understanding
of the complexity and heterogeneity of the hematopoietic system has dramatically evolved in the past 10
years. The use of high-end flow cytometry and transcriptomics allowed investigators to measure cell-to-
cell differences and correlate genomic information with single-cell function. Our understanding of non-
malignant hematology is rapidly evolving, and now requires integration of transcriptome, epigenome,
proteome (and now “organellome”) both at the single-cell level and in bone marrow in situ. However,
rigorous experimental dissection of hematopoietic stem and progenitors (HSCP) requires specialized
expertise and fascile technical agility that serves as a barrier to many researchers in the field. To answer
this critical need, the Single Cell Characterization and Procurement Core (SCCPC) is designed to provide
both expertise on data analytics platforms as well as technical advise (and access to) specialized services
to facilitate cutting-edge multi-dimensional single-cell analyses for functional and mechanistic
understanding of non-malignant hematology. Although such technologies are widely available, access to
these services at most institutions is not accompanied by requisite understanding of hematopoiesis and
stem cell biology (and/or analysis pipelines). Thus, there is a need for easy access to training and
expertise on using analytic platforms, and how to integrate datasets. The SCCPC provides unique
services for investigating hematopoiesis at the single-cell level including: (1) standardized and centralized
services in flow cytometry analysis and isolation to reduce costs for investigators; (2) specialized services
in multispectral flow cytometry and multi-dimensional analyses; (3) specialized analysis pipelines for
integrating orthogonal “omics” layers; (4) specialized services in high resolution confocal
immunofluorescence imaging for fixed, live and in situ single cell imaging; (5) specialized services in
study design, large dataset analyses and interpretation; and (6) development of new cutting-edge
technologies for investigators to use in their research. The Central Goal of the SCCPC is to create a
centralized center providing advise/expertise on data analyses and integration to facilitate a
comprehensive cutting-edge multi-dimensional single-cell understanding – functionally and
mechanistically – of non-malignant hematology. The SCCPC has dedicated professionally trained staff
with great experience in scientific experimental design and client support. The aims of the core are to
provide innovative, state-of-the-art facilities and sophisticated technical assistance for high quality
analysis of single hematopoietic cells; to provide uniform quality of cell preparations; to reduce costs of
individual investigators by using shared flow cytometry, genomics analyses and imaging facilities; and to
train/educate in new concepts on cell analysis, isolation, bioinformatics analyses and imaging.